The impact of social drivers, conditional cash transfers and their mechanisms on mental health of the young: an integrated retrospective and forecasting approach using the 100 million Brazilian Cohort

PROJECT SUMMARY
Physical, emotional, and social changes, including exposure to poverty, abuse, or violence, increases youth
vulnerability to mental illness. These factors interfere with development, limit opportunities, and hamper
achievement of a fulfilling life as adults. Addressing these issues can lead to improved outcomes at the
population level and better cost-effectiveness for health services. This should be especially important to low- and
middle-income countries, due to the substantial number of financially and socially vulnerable individuals in these
settings.
Cash transfer programs have been a promising way to address some of the social drivers for poor mental health
among youth. It has been shown that such programs can alleviate income restriction, increase schooling and
access to health facilities, and decrease alcohol consumption and violence in families. However, it is still unclear
which pathways and mechanisms explain the association between socioeconomic support and lower mental
illness among youth.
In this project, we will evaluate the effect of social drivers on youth mental health-related hospitalizations and
suicide, test mechanisms and pathways of a countrywide socioeconomic intervention, and examine the timing
of the intervention during the life course. For example, determining whether cash transfers delivered earlier in
life can contribute to better outcomes over time. This project will also investigate the cash transfer effect on
vulnerable groups (African descendants, women, and youth with lower income).
We will evaluate social drivers’ determination and the association between being beneficiaries of the Conditional
Cash Transfer program, called the Bolsa Família Program (BFP), and mental illness and its long-term effects
using robust methodologies for big datasets, such as Regression Discontinuity Designs, Propensity Score
Matching and difference-in-differences. We will test mechanisms and pathways, between BFP and mental
health-related hospitalizations and suicide among youth using Structural Equation Modeling. Furthermore, we
will perform microsimulations to generate projections regarding how mental health-related hospitalizations and
suicide trends will be in the future based on the current state, and how BFP implementation scenarios will affect
these trends.
The results of this project will be of vital importance to guide policies and programs to improve mental health and
reduce mental health-related hospitalizations and suicide in youth. It will provide information to improve the
effectiveness of these programs worldwide. Finally, it can potentially advance the global debate on the economic
response to the pandemic and times of economic crises. If cash transfers can decrease mental health problems
among youth and reduce suicide, it will have a dramatic impact on saving lives.

Public health relevance
PROJECT NARRATIVE Psychiatric disorders in youth are very difficult to predict and prevent but addressing the drivers of mental illness during the developmental phase of the life course offers a critically important opportunity to reduce the global burden of mental disorders in youth people and over the life course. In this project we will investigate social drivers, pathways and mechanisms through which a large cash transfer program is associated with better mental health outcomes among youth, thus attempting to reveal avenues for prevention, using an unprecedent cohort of over 100 million in Brazil. Results from this innovative project are expected to inform policymakers in ways of addressing the burden of mental illness through social protection programs for youth.